PET imaging of dynorphin/kappa-opioid reactivity to stress in depression

PROJECT SUMMARY/ABSTRACT: Major depressive disorder (MDD) is a leading cause of disability worldwide
with a paucity of personalized, efficacious treatments. Life stressors have long been shown to potently predict
depressive symptomatology and onset of major depressive episodes. Despite this, the neurobiological
mechanisms underlying stress regulation in depression are not yet fully understood in humans. Preclinical and
initial human studies implicate kappa-opioid receptor (KOR) deficits in the pathogenesis of MDD and suggest
that stress reactivity might contribute to these KOR deficits. The innovative study proposed in this K01 represents
a first step to determine if KOR binding deficits and heightened dynorphin/KOR-mediated stress reactivity are
observed in MDD relative to healthy controls (HCs). If shown to be so, then the second step will be to determine
whether these deficits represent a state effect that it is present in currently depressed and not in euthymic
subjects with MDD or a trait effect present in both currently depressed and remitted MDD (to be tested in a
follow-up R01). Therefore, we seek to evaluate KOR binding at rest and endogenous dynorphin release to a
laboratory stressor in unmedicated, currently depressed participants with MDD vs. HCs. KOR binding and
dynorphin release will be quantified in vivo in humans with functional positron emission tomography (PET) with
the new tracer [11C]EKAP, already reliably synthesized and used in rodents at the Columbia PET Center, that
targets KOR with high sensitivity and specificity. A brief, validated stress task with physiologic and psychologic
components will be given during the PET scan that elicits hypothalamic-pituitary-adrenal (HPA) axis activation.
Physiologic markers of HPA activation will be acquired proximal to the task, e.g., cortisol, to be compared with
KOR binding at rest and stress-induced endogenous dynorphin release in MDD vs. HCs. Further, the Principal
Investigator’s (PI) preliminary studies suggest that smartphone-administered ecological momentary assessment
(EMA) of daily stressors is greater in depressed relative to control participants and has distinct structural and
functional neural correlates. In this study, EMA of daily stressors will be acquired and evaluated to determine if
daily stress preceding the PET scan, as well as preceding a structural magnetic resonance imaging (MRI) scan,
modulate brain structure, KOR binding, and stress-induced endogenous dynorphin release in depression. This
will be the first study to investigate KOR’s role in stress-reactivity in vivo in MDD, and will combine multimodal
neuroimaging, peripheral markers of HPA activation, and EMA daily stress. Regardless of the outcome of this
study, it will increase our understanding of KOR’s role in MDD and in dysregulated stress reactivity in MDD,
potentially suggesting KOR-regulated, stress-sensitive depression subtypes. This award will measurably
advance the PI’s training in conducting highly impactful research studies and understanding the neurobiology of
mood disorders. This will propel the PI toward research independence, launching her research program aimed
at elucidating the consequences of stress in mood disorders and developing interventions to mitigate them.

Public health relevance
PROJECT NARRATIVE Depression is a highly prevalent, debilitating condition with a lack of targeted, personalized treatments and we do not yet know how life stressors neurobiologically contribute to depression onset and progression. This research study seeks to uncover how stress-sensitive neural processes differ and are differentially modulated in depressed humans relative to controls. Results will inform development and improvement of targeted depression treatments that can mitigate and/or obviate the biological consequences of stress.